Mission Empower

Project Summary: Mission Empower: Health
According to the Society of Public Health Education, only 7.5% of K-5 schools nationally provide sufficient
health education (Society for Public Health Education, 2017). IDM and game-based learning strategies have
the potential to help close this gap but, to date, most public health solutions have not been scalable (Zamboni,
et al 2019). Too often IDM and health solutions are employed in ways that fail to provide teachers insight into
resources or a coherent vision for how the products can be effectively used to advance student learning (Pan
et al, 2021; Darling-Hammond & Zielezinski, 2014). The problem is particularly acute in elementary STEM and
health education, and most accentuated among low-income students and students of color, in whom
meaningful STEM and health education opportunities are negligible, thus hindering their STEM identity
development (Martin-Hansen, 2018).
Mission Empower.was developed to greatly reduce this STEM/health access gap. Thus, the present project
was developed to provide a scalable public health solution for the 4th and 5th grade classroom. It pilots, tests
and evaluates two hybrid, project-based learning modules that will enable 4th and 5th grade elementary
teachers to embed public health topics in their core science curriculum and link the learning to the STEM
standards the students must master.
This project is significant because it will employ interactive digital media (IDM) and game-based learning
practices to increase the adoption of public health curriculum by educators within their core science block. By
using a project-based learning approach we will provide teachers a clear, adoptable framework that allows
them to easily implement scalable public health information for students. The resulting prototypes will serve as
the template for a year-long, standards-aligned, IDM curriculum in public health that will eventually include
eight full projects, i.e., “Mission Empower.”
This project is innovative in that it employs research on scaling public health curriculum with the best of IDM
and game-based learning research within one easy to adopt framework of project-based learning. We will
embed the best of game-based learning strategies and interactive games with-in a seamless, easy to use
student experience that gives teachers choice over sequencing of learning and the tools needed to monitor
student progress through badging and data. By leveraging technology to create a streamlined, simple solution,
Mission Empower will ensure scalability and adoption by teachers, leading to increased student access to
knowledge that will enhance their stem identities and, eventually, increase the number of students who pursue
STEM and health careers.
In this Phase I SBIR we will: 1) Develop one initial hybrid learning module prototype, 2) Employ focus groups
and authentic user tests with 30 teachers, and 3) Create a second module informed by the first prototype.

Public health relevance
PROJECT NARRATIVE - RELEVANCE TO PUBLIC HEALTH Mission Empower will create a scalable public health solution that combines interactive digital media, game-based learning and project-based learning to significantly increase public health literacy. Each module will grow educator and student knowledge of core public health challenges to make better informed health choices, build STEM identities, and increase the diversity of students who pursue STEM and health-related careers.